Ion channel regulation of pancreatic islet cell function

Project Summary/Abstract
It is estimated that 1 in 4 Veterans suffer from diabetes, and, in the Veteran population, this is largely Type 2
diabetes. This condition drives heart disease, stroke, retinopathy, nephropathy and neuropathy, all of which
are a cause of significant morbidity and mortality among our Veterans. As such, understanding the biology of
diabetes, discovering novel molecules that regulate b-cell function and developing innovative therapeutic
approaches will have a significant impact on the health of our aging veteran population. Type 2 diabetes is
characterized by both a loss of insulin sensitivity and, ultimately, a relative loss of insulin-secretion from the
pancreatic b-cell. Insulin secretion from the pancreatic b-cell is triggered by Ca2+ influx through voltage-gated
Ca2+ channels (VGCC) to trigger insulin vesicle fusion with the b-cell plasma membrane.
We recently reported that SWELL1 (LRRC8a), a member of the Leucine Rich Repeat Containing protein
family, is required for ICl,SWELL in β-cells. SWELL1-mediated ICl,SWELL activates upon b-cell swelling induced by
glucose import, and this generates a depolarizing current contributing to VGCC activation, thereby regulating
insulin secretion and systemic glycemia. Indeed, mice with SWELL1-deficient β-cells exhibit impaired glucose-
stimulated insulin secretion and glucose intolerance. Moreover, we find that ICl,SWELL is reduced in both mouse
and humans in the context of Type 2 diabetes (T2D) indicating that reduced SWELL1 signaling is associated
with impaired b-cell function in T2D. The objective of the current proposal is to delineate the mechanisms by
which SWELL1 signaling regulates b-cell function, under basal conditions, and in the setting of Type 2
diabetes. Our central hypothesis is that SWELL1 regulates both glucose-stimulated insulin secretion and
PI3K-AKT-mTOR signaling in b-cells to maintain systemic glycaemia, and that impaired SWELL1
signaling contributes to b-cell failure in Type 2 diabetes. The contribution of this proposal is significant
because it explores the innovative concept the SWELL1 utilizes dual signaling domains (channel versus
LRRD) to regulate b-cell function in health and T2D. Importantly, this proposal will also define the relationship
between b-cell SWELL1 and T2D and test the notion that reduced SWELL1 signaling may drive impaired b-cell
function in T2D. We propose the following two AIMs:
AIM#1: Delineate the mechanism(s) of SWELL1-mediated regulation of excitation-secretion coupling.
AIM#2: Dissect the molecular mechanisms of SWELL1 macro-complex regulation of AKT-mTOR
signaling in b-cells.
The contribution of this proposal is innovative because it delineates a novel SWELL1 signaling pathway that
connects glucose-mediated b-cell swelling to b-cell depolarization and insulin-release - a form of b-cell swell-
activation or “swell-secretion” coupling. This proposal will enhance our understanding of b-cell biology and help
direct novel therapeutic approaches to b-cell failure in Type 2 diabetes.
!

Public health relevance
Project Narrative Diabetes and associated diseases are major health concerns in today’s society. The proposed research is relevant to the mission of the VA because it provides mechanistic and pathophysiological insight into a novel signaling pathway in pancreatic b-cells. Delineating this pathway will expand our knowledge base in b-cell biology and may provide an innovative therapeutic target for the treatment and prevention of diabetes which is prevalent in the VA population.